Bilateral Acoustic Sensing and Automated Breathing Segmentation for Remote Monitoring of Patients with COPD: A Longitudinal Study

Abstract: Chronic obstructive pulmonary disease (COPD) is one of the most costly and lethal chronic conditions, with a
23% readmission rate in the United States contributing over $52 billion in annual expenses. WearME—our patented
wearable harness—addresses a gap in COPD care by allowing continuous, passive respiratory monitoring that does not rely
on patient-initiated spirometric maneuvers. This innovative platform captures bilaterally segmented lung acoustics, cough
frequency, and respiratory rhythms, enabling clinicians to detect early exacerbations and intervene preemptively. Our NIH-
funded Fast-Track SBIR activities are designed to validate the device’s clinical performance, but successful
commercialization also demands an evidence-based approach to market entry.
Participation in the I-Corps program will allow our multidisciplinary team—comprising expertise in engineering,
medicine, and entrepreneurship—to conduct extensive stakeholder engagement. Through at least 100 interviews, we will
refine our assumptions about how best to distribute WearME (e.g., partnering with durable medical equipment distributors
versus direct hospital sales), how to optimize payer reimbursement for remote patient monitoring codes, and whether to
pursue a strategic acquisition by a major MedTech firm. This systematic discovery process is essential for honing WearME’s
business model and ensuring its commercial viability. By the end of the program, we aim to finalize a blueprint for scaling
WearME to broader markets, complete with validated pricing, market positioning, and distribution strategies, thereby
fulfilling our vision of making continuous lung monitoring readily accessible to millions of COPD patients worldwide.
1

Public health relevance
Narrative: Chronic obstructive pulmonary disease (COPD) imposes a significant societal burden, with a 23% hospital readmission rate and billions in annual costs. To address this challenge, LASARRUS has developed WearME, a patented wearable harness that continuously monitors lung acoustics, enabling proactive interventions and improved patient outcomes. While Phase I SBIR results confirm clinical feasibility, the I-Corps program will guide our commercialization pathway through direct stakeholder interviews. By exploring potential distribution models, reimbursement frameworks, and strategic partnerships, our team will validate assumptions related to market demand and payer adoption. The ultimate goal is to align WearME’s design, pricing, and deployment strategies with real-world needs, accelerating its availability to the COPD population and laying the groundwork for broader, scalable impact.